Harnessing the potential of GPCRs localized to the primary cilium for the treatment of renal disease

!#$%$&'()*$&+,',#)-$(./.%#+/)0+1,2.)*+%2'%2)3!*-0*4)+%)')56$762%%+82)1+%2'%2)$9)62,'()1.%9,/#+$,) &'6:21);.)/.%#)9$6&'#+$,)',1)76$%%)2,('672&2,#)$9)#<2):+1,2.=)><2)/$,1+#+$,)'992/#%)',)2%#+&'#21)?@A@@@) B=C=)D2#26',%=)!(#<$7<)/.%#%)'62)%$&2#+&2%)28+12,#)2'6(.)+,)(+92A)!*-0*)72,26'((.)<'%)',)E'1(#F)$,%2#=) G+(+#'6.)526%$,,2()'62),$#)%/622,21)9$6)#<+%)1+%$6126)56+$6)#$)2,#26+,7)#<2)'6&21)%268+/2%)',1)'62)#<%)$9#2,) 1+'7,$%21)$,(.)16+,7)$6)'9#26)#<2+6)&+(+#'6.)1#.=)H'(9)$9)#<2%2)+,1+8+1'(%)I+(()2J526+2,/2)/$&5(2#2)62,'() 9'+(62);.)#<2)'72)$9)K@A)62L+6+,7)(+92M($,7)1+'(.%+%)',1N$6)282,#'()$67',)#6',%5(',#'#+$,)9$6)%68+8'(=)><2%2) ',1)$#<26)/$&5(+/'#+$,%)$9)#<2)1+%2'%2)32=7=)(+826)9'+(62A)<.526#2,%+$,A)'66<.#<&+'A)',1)56$52,%+#.)9$6) /262;6'()',26.%&4)'62)2J52/#21)#$)2J'/26;'#2)+((,2%%2%)+,)',)'7+,7)D2#26',)5'#+2,#)5$5('#+$,)'(62'1.) /$&56$&+%21);.)$#<26)%268+/2M/$,,2/#21)/$,1+#+$,%=))))) ) !*-0*)+%)129+,21)'%)')E/+(+$5'#<.FA)')1+%2'%2)62%(#+,7)96$&)1292/#+82)%#6/#62N9,/#+$,)$9)#<2)56+&'6.) /+(+&A)')#+,.)$67',2((2)#<'#)+,)#<2):+1,2.)#;(2)2J#2,1%)96$&)#<2)'5+/'()5('%&')&2&;6',2)+,#$)#<2)#;(2) (&2,=)>I$)56$#2+,%)#<'#)'62)&#'#21)+,)!*-0*A)#<2)E5$(./.%#+,%F)3-0*O)',1)-0*P4A)9$6&)')<2#26$1+&26)+,) #<2)/+(+&=)><+%)($/'(+Q'#+$,)+%)%$&2<$I)2%%2,#+'()9$6)56282,#+,7)#<2)/2((('6)56$(+926'#+$,A)9+;6$%+%)',1) '6/<+#2/#6'()62&$12(+,7)$9)#<2):+1,2.)#;(2)62%5$,%+;(2)9$6)72,26'#+,7)#<2)&'%%+82)2,/($%21)/.%#%) /<'6'/#26+%#+/)$9)#<2)1+%2'%2=)!,)!*-0*)167)3#$(8'5#',4)I'%)'556$821)+,)P@OR);#)56$8+12%)$,(.) %.&5#$&'#+/)62(+29)9$6)5'#+2,#%A)56+,/+5'((.);.)621/+,7)#<2)/./(+/)!G-)3/!G-4M1252,12,#)9(+1)',1) 2(2/#6$(.#2)%2/62#+$,)#<'#)16+82%)62,'()/.%#)2,('672&2,#=) ) S2I)%#1+2%)5;(+%<21)('%#).2'6)+,1+/'#2)#<'#)')/+(+'6.)%+7,'(+,7)5'#<I'.)56$&+,2,#)+,)1282($5&2,#)',1) #&$6)9$6&'#+$,A)H2172<$7)3H<4A)+%)';266',#(.)'/#+8'#21)+,)!*-0*=)T82,)&$62)62/2,#(.A)$6)(';)%<$I21) #<'#)H<)%#+&('#+$,)56$&$#2%)#<2)'/#+8+#.)$9)%52/+9+/)UM56$#2+,M/$5(21)62/25#$6%)3U-VW%4)/$,9+,21) 2J/(%+82(.)#$)#<2)/+(+'6.)&2&;6',2=)><+%)'(($I%)'7$,+%#M1252,12,#)/!G-)%+7,'(%)#$);2)72,26'#21)%$(2(.) I+#<+,)#<2)&+/6$1$&'+,)$9)#<2)/+(+&=)X2/'%2)#<2)/+(+'6.)H<)5'#<I'.)+%)+,<+;+#21);.)/!G-A!#$%$!&'()%! *+$%$,!-!.,/0.$!1**1+.,/2!1!%$3$4/5$32!/,$+5$,$!1,!6#!%/7,-3/,7!8/#1.!%/9.3-/,7!#$! 731:-3! /,4+$-%$%!/,!4;<'!#-!=+/5$!>3./=!%$4+$/1,=) ) ><2)$826'(()565$%2)$9)#<2)562%2,#)56$Y2/#)+%)#$)28'('#2)#<2)5$#2,#+'()$9)#<+%),2I(.)12%/6+;21)/+(+'6.)U-VWM 1252,12,#)/!G-)%+7,'(+,7)/+6/+#)#$)'(#26)-0*)56$762%%+$,=)Z+6%#A!%+,7)$5#+/'()'556$'/<2%)1282($521)+,)$6) (';)9$6)&2'%6+,7)+,#6'/+(+'6.)/!G-A)I2)I+(()12#26&+,2)I<.)H<)%#+&('#+$,)(2'1%)#$)',)'55'62,#)5627('#+$,) $9)U-VW)9,/#+$,)',1)/!G-)%+7,'(+,7)2J/(%+82(.)+,)#<2)/+(+&)',1)<$I)#<+%)+%)'992/#21);.)62(28',#) 5$(./.%# +,)&#'#+$,%=))S2J#A)/$,%+126+,7)#<'#)#<+%),2I)%+7,'(+,7)%.%#2&)56$1/2%)/!G-)%+7,'(%)$,(.)+,)#<2) /+(+'6.) &+/6$1$&'+,A)I2)I+(()129+,2)#<2)#6',%/6+5#+$,'()5'#<I'.%)#<'#);2/$&2)'/#+8'#21)%52/+9+/'((.);.)#<2%2)($/'() /<',72%)+,)%2/$,1)&2%%2,726=)Z+,'((.A)<'6,2%%+,7)#<2)5$#2,#+'()$9)U-VW%)+,)#<2)/+(+&)#$)/$,#6$()62,'() 5'#<$($7.)62L+62%)'11+#+$,'():,$I(2172)';$#)#<2+6)+12,#+#.)',1)($/'#+$,)I+#<+,)/.%#M(+,+,7)25+#<2(+'A)+,) '1Y'/2,#),$6&'()62,'()#;(2%)',1)+,)#<2)%66$,1+,7)%#6$&'()/2((%=)[2)I+(()#<2629$62)%2)%+,7(2)&$(2/(2) Z\CH)3%&Z\CH4)#$)+&'72)/$5.),&;26)',1)%5'#+'()1+%#6+;#+$,)$9)#6',%/6+5#%)9$6)56$%52/#+82)/+(+'6.)U-VW%) +,) !*-0*)62,'()%52/+&2,%=)><2)$826'(()7$'()+%)#$)+12,#+9.),$82()',1)5$#2,#+'((.)1677';(2)U-VW %)#<'#)&'.);2) %21)#$)%2(2/#+82(.)2(+/+#)/!G-)%+7,'(%)I+#<+,)#<2)/+(+&)I+#<$#)'992/#+,7)%2/$,1)&2%%2,726) (282(%)+,)#<2) 62%#)$9)#<2)/2((=)

Public health relevance
Autosomal Dominant Polycystic Kidney Disease (ADPKD) is a common cause of kidney and liver dysfunction that significantly reduces life expectancy and severely impacts quality of life in Veterans and their dependents. This costly disease ($2 billion/year) is caused by mutations in two proteins of unknown function called "polycystin 1" and "polycystin 2" that are associated with disturbances in intracellular signaling patterns of an important messenger molecule known as cyclic AMP (cAMP). Human clinical drug trials showed that the cAMP pathway is a promising target for controlling cyst growth in ADPKD, but existing drugs do not address the complete spectrum of the disease process. Our results indicate that cAMP could have positive and negative effects on cyst expansion depending on where in the cell this signal is generated. By investigating the finer details of how localized cAMP signals work in ADPKD cells, we expect to find more selective ways to inhibit cyst growth, and ultimately to preserve kidney function.